From Rare to Care: Discovery, Modeling and Translation of Rare Diseases

ABSTRACT Support is requested for a Keystone Symposia conference entitled From Rare to Care-Discovery, Modeling and Translation of Rare Diseases, organized by Drs. Josef M. Penninger and Kym Boycott. The conference will be held in Vienna, Austria from November 11-15, 2018. Work over the past 30 years has resulted in the identification of genes for ~50% of the estimated 7,000 rare genetic diseases; it is predicted that most of the remaining disease genes will be identified in the next 10 years. Approximately 500 medicinal products are currently on the market for rare diseases. The accelerating pace of rare disease gene identification means, in effect, an almost commensurate increase in molecularly defined, readily diagnosable, but nonetheless poorly understood and untreatable, diseases. This meeting will examine the current and future bottlenecks to gene discovery, disease modeling, and therapeutic approaches and suggest strategies to enable progress in this regard. Ultimately, successful deployment of precision medicine for rare diseases will inform such approaches more broadly.

Public health relevance
PROJECT NARRATIVE This conference will occur at a time when the rare disease field has begun to transition from early stage investigation to a field where translation is the ultimate goal. New technologies are having significant impact on all aspects of rare disease investigation and include approaches such as genomic sequencing complimented by other ‘omic approaches, CRISPR-Cas9 and iPS cells, organoid modeling, and examples of successful therapeutic development such as gene therapy. We aim for this meeting to promote an interdisciplinary assessment of where the field is going and to explore how best to navigate bottlenecks and hurdles to fully realizing the potential of this field for improving human health.